NON-STEADY STATE STUDIES OF FREE FATTY ACID FLUX

To determine whether steady state or non steady state equations provide the best estimate of free fatty acid flux under conditions of known and changing FFA rate of appearance.